Association of Denosumab Therapy with Tooth Root Resorption

PROJECT SUMMARY/ABSTRACT
Tooth root resorption mediated by osteoclasts (OCs)/odontoclasts is a normal physiologic process
required for the exfoliation of primary teeth to make space for the eruption of permanent teeth.
However, root resorption of permanent teeth is pathological. Multiple External Cervical Root
Resorption (MECRR) is an aggressive form of pathologic root resorption that affects multiple teeth
at the cemento-enamel junction. The precise etiology of MECRR remains unknown, and MECRR
lesions are often detected incidentally during routine dental exams. They are resistant to
interventions, resulting in significant tooth loss. Our preliminary data indicate a critical link
between denosumab (DMAb) therapy and MECRR. DMAb therapy appears to initiate MECRR,
and its discontinuation leads to a rapid progression of MCERR. DMAb is an antiresorptive
medication used to treat osteoporosis, bone metastases, and fibrous dysplasia. DMAb inhibits
receptor activator of nuclear factor-κB ligand (RANKL), thereby preventing OC formation, function,
and survival. To date, the direct causal role of DMAb in MECRR initiation and progression remains
unknown. The objective of this proposal is to elucidate the causal role of DMAb in MECRR using
clinical and pre-clinical models. Our central hypothesis is that prolonged DMAb therapy
increases MECRR susceptibility, and its cessation accelerates MECRR progression due to a
rebound OC effect. This hypothesis will be tested using two complementary Specific Aims that
leverage clinical, animal, and in vitro studies. In Aim 1, through clinical study we will measure the
prevalence, association strength, and risk factors for MECRR. In Aim 2, through murine studies
we will establish the causal role of DMAb therapy in MECRR susceptibility and how its cessation
accelerates MECRR. The proposed research is significant as it addresses a critical knowledge
gap in the pathogenesis of MECRR. By providing mechanistic insights into the initiation and
progression of MECRR, our study aims to advance scientific knowledge and transform clinical
practices. This research will help identify patients at risk for DMAb-related MECRR and inform
novel preventive and therapeutic strategies. Moreover, our findings will have broader implications
for understanding OC dysfunction in other conditions such as osteoporosis, bone metastases,
and fibrous dysplasia.

Public health relevance
PROJECT NARRATIVE Public Health Relevance: Multiple External Cervical Root Resorption (MECRR) is an aggressive form of root resorption affecting multiple permanent teeth, with an unknown cause and resistance to intervention, resulting in significant tooth loss. Our preliminary data reveal a critical link between denosumab (DMAb), an anti-resorptive medication, and MECRR. The proposed research is of public health relevance as it will provide new knowledge about the role of DMAb in MECRR, aiding in the development of novel clinical therapies for MECRR and transforming clinical practices.